HISTIDINE ON THE ACTION OF VASOPRESSIN IN DI

This project seeks to determine if the amino acid, histidine, augments the antiduiretic action of vasopressin in man, as it does in the Brattleboro rat and toad bladder.